Integrative analysis of high dimensional tissue molecular data to define key biological systems in autoimmune diseases (SBC)

PROJECT SUMMARY/ABSTRACT
Here we propose a Systems Biology Core (SBC) for the Accelerating Medicines Partnerships in Autoimmune
and Immune-Mediated Diseases (AMP AIM). The AMP AIM will use high dimensional molecular and cellular
assays to define the key cell states, pathways, and molecular components of tissue inflammation and damage
by examining patient tissue and blood samples. Ultimately, we seek to define the components of tissue
inflammation in autoimmune and inflammatory diseases including psoriatic spectrum diseases (PSD),
rheumatoid arthritis (RA), systemic lupus erythematosus (SLE), Sjogren’s syndrome (SS), and other related
conditions. AMP RA/SLE initiated this process by querying 106 single cells in inflamed RA synovial and SLE
nephritis tissue samples using multimodal strategies; it defined key cell states in tissue inflammation, including
T peripheral helper T cells (Tph), GZMK+ CD8+ T cells, HLA-DR+THY1+ fibroblasts, and autoimmune-
associated B cells (ABCs). Now, to understand how these and emerging cell-states function and interact to
cause disease, it will be essential to obtain high dimensional data on patient sample data across a spectrum of
diseases and disease sub-phenotypes. These data may capture the cellular states; the spatial localization of
cell states, proteins and transcripts; histological features; and other tissue parameters. A powerful and skilled
team that is able to define strategies to analyze this data, integrate multiple modalities of data, and integrate
results from across a diverse set of diseases and tissues will be essential to the success of this program.
We build from our experience leading the Systems Biology Group within the Accelerating Medicines
Partnerships Rheumatoid Arthritis and Systemic Lupus Erythematosus (AMP RA/SLE). We have built a team
that is skilled at analysis of diverse modalities and computational biology. We have specific experience and
expertise in inflammatory diseases. Here we propose to:
(1) Develop Tools and Technology to analyze high dimensional cellular and molecular data. This includes
optimizing existing bioinformatics and computational tools. It also includes developing new
computational and statistical methods to integrate high dimensional data manifestation of disease.
(2) Enable collaboration throughout the network and facilitate systems level analysis. We envision that this
is an integrated activity with the network, where we will devise and ultimately create an integrated
model of tissue inflammation across diseases to define features that drive clinical disease. This will
require the development of new statistical and computational methods. It will also require tight
collaboration within the network including data synchronization, storage, sharing, and clinical data
integration. In addition, we will engage the network by offering consultation, technical support and
training in high dimensional data analysis.
.

Public health relevance
PROJECT NARRATIVE Tissue inflammation is central to a wide range of human diseases, including immune-mediated and autoimmune diseases such as Psoriatic Spectrum Disease, Rheumatoid Arthritis, Sjogren’s Syndrome, and Systemic Lupus Erythematosus. The key cell-states driving tissue inflammation are now being discovered. Here we propose a Systems Biology Core to enable the AMP AIM network to define these key cell states, their spatial localization, and their interactions with each other.